Development of mmWave technology for safe radiation treatment delivery

ABSTRACT
Radiation therapy offers cures to cancer patients but also is prone to error. Although the radiation oncology
society sets up strict quality assurance and safety procedures to prevent treatment errors, they are difficult
to follow on every treatment due to time, labor cost and other constraints. Automation is highly desired to
improve treatment safety. The millimeter-wave (mmWave), which has been broadly employed to detect the
collision and prevent an accident before it happens, can penetrate the patient’s clothing, immobilization
device and tabletop, detect patient’s position automatically. Multiple mmWave devices may be installed in
the treatment room, verify setup and detect patient motion automatically when integrated with treatment
control software. The low-cost mmWave can potentially eliminate many major treatment errors without
increasing labor costs. The nonionizing mmWave can also monitor the patient’s motion continuously and
detect any intrafraction motion during treatment delivery. To achieve this goal, we will perform a study to
achieve the following specific aims (SAs) -- SA1: Develop mmWave algorithms that can measure the
absolute distance to the patient surface, and SA2: To develop and validate the mmWave technology to
monitor a patient’s movement and breathing during RT delivery.

Public health relevance
NARRATIVE Patient safety is of paramount importance in radiation oncology. The technological advancement in radiation treatment planning and delivery during the last thirty years resulted in improved local tumor control and reduced toxicity for radiation treatment. However, accidental and unintended exposures still happen frequently in external beam radiotherapy, which compromise treatment outcome and endanger patients. Whilst the field of radiation therapy as a whole has been attempting to improve patient safety through the adoption of rigorous clinical workflows, new technology development that can provide additional safeguard with minimum additional cost for radiation treatment is highly desired. In this project, we will develop a low- cost mmWave technology that can automatically verify patient setup and monitor patient movement continuously through the treatment delivery. The implementation of the novel technology into radiotherapy clinics may largely avoid setup errors and inaccurate treatment delivery due to patient motion.